Neuroimmune axis contribution to the pathophysiology of pulmonary hypertension

PROJECT SUMMARY/ABSTRACT
Pulmonary hypertension (PH) is a progressive disease leading to right heart failure and an unacceptably high
mortality rate. Despite major milestones in our understanding of predisposing factors to PH, to date, we still have
limited mechanistic insight into its development and progression. Thus, despite advances in current therapies,
there is no available cure and treatment has limited improvement in outcome. Therefore, development of drug
treatments with alternate targets may benefit patients. To this end, our published and preliminary studies demon-
strate increased activated microglia, specifically TREM2-expressing disease-associated microglia, contribute to
neuroinflammation in autonomic brain regions, particularly the paraventricular nucleus (PVN) of the hypothala-
mus. These data informed our central hypothesis that activation of resident microglia, especially TREM2+
microglia subtype and infiltrated myeloid precursors, promotes aberrant preautonomic neuronal signal-
ing in the paraventricular nucleus of the hypothalamus leading to sustained sympathetic activation,
which is critical to PH. We plan to test this hypothesis via the following three aims: Aim 1 will evaluate the
microglia-dependent mechanisms that contribute to increased preautonomic neuron activity within the PVN; Aim
2 will evaluate the mechanism by which TREM2 contributes to PH pathophysiology, exploring the working hy-
pothesis that TREM2 expression within microglia is necessary and sufficient for augmented sympathetic activity
and thus, a potential therapeutic targeted. Finally, Aim 3 will test the hypothesis that chronic microglia activation
leads to dysautonomia and enhanced systemic inflammation, with consequently increase in circulating myeloid
cells infiltration to autonomic brain regions such as PVN, contributing to neuroinflammation in a feedforward loop,
worsening PH outcomes. Experiments will combine 2-photon microscopy in brain slices, flow cytometry, sympa-
thetic ablation, and several cutting-edge genetic models. Ultimately, we expect results of these studies to con-
tribute to better understanding of the mechanism whereby microglia and infiltrated myeloid precursors contribute
to the pathophysiology of PH. Collectively, the proposed studies will lead to novel information regarding the
brain’s pathogenic contribution to pulmonary hypertension, which may represent an entirely novel target for PH
therapeutics. In addition, strong mentorship by Drs. Andrew Bryant and Eric Krause, as well as a Mentoring
Committee comprised of established professors, who are experts in the proposed techniques and have extensive
mentoring experience; will provide conceptual and methodological training, to achieve the research goals and
prepare me to establish an independent research program.

Public health relevance
PROJECT NARRATIVE Sympathetic nervous system activity is increasingly appreciated as a major contributor to pulmonary hypertension severity and prognosis. Our studies focus on neuronal-immune cell interactions that seek to uncover the mechanism involved in disease-associated sympathetic activity. We focus in part on a subset of TREM2 expressing disease-associated microglia as a therapeutic target for the treatment of pulmonary hypertension and its associated end-organ damage.